Abnormal Interleukin 1-B Inflammasome Activation and Epilpesy Surgery Outcomes

Project Summary: Seizures recur in 50% of patients after temporal lobe epilepsy surgery and in 60%-70% after extra-temporal lobe epilepsy surgery. An exclusive focus on refining “epilepsy localization” has not yet drastically improved seizure outcomes. We recently proposed that de-novo epileptogenesis in genetically predisposed patients may influence “late” recurrences first manifesting after months to years of postoperative seizure-freedom. Evidence is accruing on neuro-inflammation's role in epilepsy, and genetic variation in Interleukin-1β (IL-1β) expression was linked to the risk of posttraumatic human epilepsy. We will explore the central hypothesis that genetic variability in IL- 1β and its related inflammasome translates into an altered pattern of microglial activation after epilepsy surgery, facilitating subsequent epileptogenesis in brain tissue at the edge of the resection and later seizure recurrence. Time to first seizure recurrence is our primary outcome. Spikes on 6-month postoperative EEG in patients who were seizure-free up to that point is our secondary outcome. In Specific Aim 1, we retrospectively explore the relationship between seizure outcomes and genetic variability in IL-1β and related inflammasome activation in resected epileptic brain tissue. We focus on SA1a)- the SNP) rs1143634 IL-1β gene variant ; and SA1b)- activation of the multi-protein complex controlling the synthesis of IL- 1β [the nucleotide binding and oligomerization domain like receptor family pyrin domain-containing 3(NLRP3)inflammasome], as measured by RNA/protein extraction of inflammasome components and their immunohistochemical localization to microglia. In Specific Aim 2, we explore the relationship between MRI signatures of peri-operative neuroinflammation and postoperative epileptogenesis using brain MRI done in the University of Campinas 24-72 hours after surgery. In Specific Aim 3, we expand the questions of SA1 and 2 using a prospective cohort of 25 patients enrolled from Mayo Clinic and Cleveland Clinic as we (SA3a) determine if peri-operative serum measurements of IL-1β, MMP-9, or IL-18 correlate with the primary and secondary outcome, and identify the ideal collection time to study in a future definitive project; (SA3b) study the timeframe for development of our proposed postoperative epileptogenesis biomarkers; and (SA3c) explore our proposed mechanism by studying the relative (margin vs.core of resected epileptic tissue) degree of microglial activation, IL-1β tissue expression in those with favorable vs unfavorable outcomes. Our strong preliminary data support our hypothesis. The collaboration of multiple sites (Cleveland Clinic, Mayo Clinic, and University of Campinas) will indirectly test the feasibility and build infrastructure needed for a future definitive study. We take advantage of existing resources and a track record of productive collaborations among our investigators to optimize the efficiency of study conduct and ensure study completion. If successful, this work will open the door for an innovative line of research on surgical outcomes after epilepsy surgery with a significant potential for altering clinical care given the multitude of selective IL-1β modifiers on the market.

Public health relevance
Project Narrative: When seizures continue despite aggressive and adequate medical therapy, brain surgery to remove the epileptic tissue becomes the best treatment option. However, brain surgery for epilepsy is only successful in around 50% of the cases. This project explores the idea that the inflammatory response that normally occurs in the brain after any brain surgery is abnormal in certain genetically predisposed individuals, disrupting the healing of the remaining brain and facilitating seizure recurrence. To find evidence of this abnormal neuroinflammatory response in patients with recurrent seizures after surgery, we will perform genetic studies on resected brain tissue from patients who had epilepsy surgery at the Cleveland Clinic, and analyze brain MRI pictures obtained acutely (within 24-72 hours) after epilepsy surgery at the University of Campinas, Brazil. In addition, we will enroll 30 patients undergoing epilepsy surgery at Mayo Clinic or Cleveland Clinic and study their resected brain tissue in more detail while investigating the timeline through which this abnormal neuroinflammation manifests itself in blood tests, brain wave recordings, and MRI pictures of the brain. We hope that this project will help us better understand seizure outcomes after epilepsy surgery and possibly find new ways to improve those outcomes.